DETERMINANTS OF CHILDHOOD POISON INGESTIONS

The Determinants of Childhood Poison Ingestion Study investigates the relationship between social and behavioral factors and risk of childhood ingestion of household cleaning and home repair and maintenance products.